Neighborhood opportunity and child health using a randomized trial of low-income mothers

Project Summary (30 lines)
A recent influential National Academies Report concludes that poverty during early childhood (i.e., <3 years)
may causally increase the risk of adverse physical health, mental health, and developmental outcomes. A key
challenge now involves how best to intervene on poverty to improve child health. In addition to individual
poverty, one critical aspect of income-based health disparities in the US involves neighborhood poverty. Poverty
in the US remains highly spatially patterned. Extensive research documents high levels of racial residential
segregation in the US as well geographic concentration of both poverty and affluence. Black and Hispanic racial
minority children in particular have non-overlapping worse distributions of childhood opportunity than do non-
Hispanic white children. Above and beyond individual poverty, living in disadvantaged neighborhoods may
damage child health, including via high residential segregation, limited healthy food outlets, fewer green spaces,
and higher neighborhood poverty.
We will use the R21 mechanism to explore the potentially causal role on child health of moving to neighborhoods
characterized by childhood opportunity. We will build on the NICHD-funded Baby's First Years (BFY) study,
initiated in 2018, which is the first large-scale US experiment of unconditional cash transfers to poor families
with infants. The randomized trial recruited 1,000 mothers of newborn infants with household cash incomes
below the poverty line. Mothers in the treatment group receive monthly cash payments of $333 ($4,000 per
year) for the first 52 months of the child's life, and mothers in the control group receive $20 per month. We will
use randomization to the high-cash gift in an intent-to-treat design to examine two questions. First, do mothers
with a partial alleviation of cash constraints move to neighborhoods characterized by greater childhood
opportunity? And second, are gains in child health (by age-2) in this high-cash group mediated by neighborhood
moves? We will leverage both residential address and rich child health data from BFY across three waves, as well
as neighborhood indices of childhood opportunity and geocoded distance measures, to achieve all aims. For the
child health aim, we will focus on neighborhood mediation of main effects that already have emerged by age-2:
sleep quality, increased consumption of fruits and vegetables, and mother's reduced purchasing of cigarettes.
Our work is significant in two ways. First, we focus on redressing large, widespread, and robust income-based
disparities in child health in the US. Second, we examine the important question of whether low-income parents
who are partially relieved of income constraints move to childhood opportunity neighborhoods at a sensitive
period of their child's development. Given the rigorous intent-to-treat study design and the infrastructure of BFY
to achieve our Aims, our analyses may identify causal estimates of neighborhoods on child health. Even precisely
estimated null findings for the neighborhood/child health aim hold strong scientific value since they would
suggest non-neighborhood mediators through which income affects child health.

Public health relevance
Project Narrative (Relevance to Public Health) We will use the first large-scale randomized controlled trial of an unconditional cash transfer program in the US to examine whether poverty reduction stimulates family moves to less disadvantaged neighborhoods. The proposed work examines the potentially causal role on child health of moving to neighborhoods characterized by childhood opportunity. We expect that results will identify, among the high-risk group of children born into poverty, specific aspects of the neighborhood and of children's health that may respond to experimental poverty reduction efforts.